Development of a Nanoparticle-Based Gene Editing Technology for Neurological Applications

CRISPR-based gene editing of the brain has the potential to revolutionize the treatment of neurological diseases.
A large number of incurable brain diseases, such as Huntington's, Alzheimer's and Parkinson's disease, are
caused by the over-expression of pathogenic proteins and could be treated with CRISPR based therapeutics.
However, despite its potential, developing CRISPR based therapeutics for the brain has been challenging
because of delivery problems. In particular, two key challenges need to be solved before gene editing in the
brains of large animals and in humans is possible. First, strategies for efficiently and safely delivering Cas9 and
gRNA into neurons, after an intracranial injection, need to be developed. Second, strategies that can enable a
large volume of brain tissue (> 1 cm) to be transfected after an intracranial injection of CRISPR reagents also
need to be developed.
The central objective of this proposal is to develop a delivery strategy for gene editing the brains of large animals
after an intracranial injection, termed convection-enhanced CRISPR (C-CRISPR). C-CRISPR is based on using
convection-enhanced delivery (CED) to deliver an engineered Cas9 RNP, which has been fused to multiple
nuclear localization signals (NLS), and has been encapsulated in PEGylated block copolymers. C-CRISPR
addresses the key translational bottlenecks that have prevented CRISPR from having a translational impact in
the brain. In particular, because it delivers the Cas9 RNP directly, it avoids the toxicity problems of viruses and
the manufacturing challenges of using mRNA, and consequently has great translational potential. In addition,
C-CRISPR uses CED to distribute the Cas9 RNP across centimeters of brain tissue, and therefore has the
potential to edit the brains of large animals. C-CRISPR is based on our preliminary data demonstrating that the
Cas9 RNP fused to multiple NLS signals can edit genes in murine brains after an intracranial injection, and that
Cas9 RNP complexed to PEG-block copolymers can be delivered to centimeters of brain tissue, in the striatum,
after delivery via CED. CED of engineered Cas9 RNP complexed to PEG block copolymers, therefore, has the
potential to edit genes in human patients. We propose therefore the following aims/milestones:
UG3 Specific Aim 1. Develop C-CRISPR formulations that distribute throughout the striatum of rats
UG3 Specific Aim 2. Develop C-CRISPR formulations that edit centimeters of brain tissue
UH3 Specific Aim 1. Develop C-CRISPR formulations that edit centimeters of tissue in pig brains
The experiments in this proposal are significant because, if successful, C-CRISPR will be the first example of a
non-viral delivery strategy that can edit genes in the brains of large animals. The experiments in this proposal
are innovative because C-CRISPR is the first example of a delivery strategy that effectively integrates 3
complementary technologies, (1) engineered Cas9 RNPs (2) PEGylation and (3) convective enhanced diffusion,
and will provide a roadmap for developing strategies for gene editing in higher animals.

Public health relevance
The purpose of this project is to develop a versatile technology for editing defective genes in the brain. We will use a combination of advanced neurosurgical delivery and novel nanoparticle formulations to delete reporter genes in small and large brains. By the end of the project, we hope to have defined a formulation ready for translation into the clinic.